Structural modeling of neoantigen presentation for rational design of heteroclitic neoepitope vaccines

Project Summary
Pancreatic ductal adenocarcinoma cancer (PDAC) is highly resistant to frontline surgical resection and
chemotherapy treatments. Many treatment-resistant cancer types have benefited from immunotherapies that
activate cytotoxic anti-tumor T cells against the somatic mutations, or neoantigens, expressed in cancer cells.
One major challenge to the development of neoantigen-targeted immunotherapy for PDAC has been the low
number and weakly immunogenic profile of identified neoantigens. Efficient activation of neoantigen-specific T
cells is dependent on the recognition of 8- to 11-mer neoepitopes displayed on human leukocyte antigen (HLA)
class I molecules. This recognition is the culmination of the biophysical and stereochemical contacts between
the peptide, HLA, and T cell receptor (TCR) molecules. One mechanism to improve neoepitope
immunogenicity is by modifying the peptide amino acid residues to enhance HLA binding or TCR recognition,
thereby enhancing cognate T cell activation, while conserving reactivity to the parental epitope. These modified
epitopes are termed heteroclitic epitopes. However, the stereochemical features of heteroclitic epitopes that
enhance HLA binding or TCR recognition are understudied. Additionally, heteroclitic epitopes have been
explored in the context of a limited number of HLA subtypes, restricting their development and application
across patients. We hypothesize that rational design of heteroclitic neoepitope vaccines through structural
modelling will improve T cell responses against PDAC neoantigens. To address this hypothesis, we will define
the structural binding and spatial display dynamics of both shared and private PDAC heteroclitic neoepitopes in
diverse HLAs. Among shared neoantigens expressed in PDAC, activating mutations in KRAS at codon 12 are
present in up to 80% of PDAC tumors. In Specific Aim 1, we will interrogate the structural mechanics and
immunogenic profile of heteroclitic KRAS G12D/V/C epitopes in a panel of 18, globally representative HLA
subtypes. In Specific Aim 2, we will develop a computational pipeline to identify, prioritize and optimize patient-
specific heteroclitic neoantigen vaccine candidates based on structural epitope features. We will use HLA
binding measurements and T cell reactivity assays to validate immunogenic features of our computationally
modelled heteroclitic epitopes. Together, these aims will define the structural features of immunogenic
neoantigens in diverse HLAs, generate heteroclitic epitope vaccine candidates for shared and private PDAC
antigens, and improve the therapeutic potential of cancer vaccines for hard-to-treat cancers such as PDAC.

Public health relevance
Project narrative Immunotherapy activates a patient's immune system to detect and kill cancer cells by recognizing the mutated proteins they express, called neoantigens. In this proposal, we investigate what these neoantigen look like to our immune system and how this information can be used to improve neoantigen-targeted cancer vaccines.